Mechanistic and Therapeutic Role of the TLR4 Signaling Pathway in Type 1 Diabetes

Type 1 Diabetes (T1D) is caused by autoimmune destruction of insulin-producing pancreatic beta cells. T1D
therapies have largely failed in human clinical trials and thus an urgent need exists for targeting novel immune
pathways. We have exciting data showing that a TLR4/MD2 agonistic antibody (TLR4-Ab) permanently reversed
T1D in 71%, and had a significant clinical effect in 90%, of acutely diabetic non-obese diabetic (NOD) mice. In
our recent Diabetes paper, we showed that TLR4-Ab can mobilize and activate myeloid-derived suppressor cells
(MDSC) in vivo, that suppress T cells and ameliorate acute T1D upon adoptive transfer. We showed that TLR4-
Ab induces TLR4/MD-2 sequestration in endosomes, unlike the canonical TLR4 agonist LPS (which cannot
reverse T1D); however, the mechanism by which TLR4-Ab reverses T1D remains unclear. We have now
produced anti-human TLR4 antibodies, allowing us to apply these findings to human T1D. Our combined
expertise in autoimmunity/T1D (Ridgway), molecular biophysics/Immunology (Herr) and human T1D (Dolan) is
well suited to perform these studies. We will pursue three aims: Specific Aim 1. Mechanism of reversal of T1D
by TLR4-Ab-induced MDSCs. TLR4-Ab endosomal sequestration may induce prolonged signaling via the
TLR4-mediated TRIF pathway, which protects from T1D (2015, Chervonsky et al.). We show that immobilization
of TLR4-Ab on a plate, which prevents endosomal sequestration, eliminated TLR4 signaling. Therefore, we
hypothesize that TLR4-Ab-induced TLR4/MD2 endosomal sequestration causes sustained TRIF endosomal
signaling that induces APCs to undergo MDSC maturation, inducing immune regulation and reversing T1D.
Specific Aim 2. Mechanistic role of Fc structure in TLR4-Ab reversal of T1D and cell suppression. While
antibody F(ab) structure determines specificity, the Fc region contributes to antibody function through receptor
binding and glycosylation. TLR4-Ab is an IgG3 isotype, which has the longest hinge region and increased
glycosylation sites. IgG3 antibodies also form cryoglobulins, impacting avidity and internalization. Our preliminary
data show that TLR4-Ab F(ab) and F(ab’)2 fragments elicit decreased NFκB signaling compared to full-length
TLR4-Ab. This shows a critical role for Fc structure in TLR4-Ab function. Therefore, we hypothesize that the
IgG3 Fc portion of the TLR4-Ab is critical to its tolerizing function and we will test this with immunological and
molecular biophysical approaches. Specific Aim 3. Testing therapeutic effects of a novel panel of human
anti-TLR4 antibodies on human T1D APCs Since the TLR4/MD2 pathway is strongly evolutionarily conserved,
we have developed agonistic human recombinant TLR4-Ab (hTLR4-Ab). We show here that these hTLR4-Abs
bind to, and activate TLR4/MD2. Our hypothesis is that hTLR4-Ab treatment will induce MDSCs from myeloid
precursors and that these huMDSCs will suppress human T-cell proliferation and activation. These studies will
characterize novel innate immune mechanisms by which TLR4-Ab treatment can reverse acute T1D, and our
studies on the novel human TLR4 antibodies are the first step in translation to human T1D.

Public health relevance
Type 1 Diabetes (T1D) is caused by autoimmune destruction of insulin-producing pancreatic beta cells. T1D therapies have largely failed in human clinical trials and thus an urgent need exists for targeting novel immune pathways. We show that a TLR4-Ab can reverse acute T1D by inducing myeloid-derived suppressor cells; we will demonstrate the mechanisms of this novel treatment, and we have developed and will test a panel of human TLR4-Abs to apply this work to human T1D.